The ancestry of animal cell differentiation and pluripotency

ABSTRACT
Animals build their multicellular bodies with diverse types of cells that perform and integrate distinct
functions. Animals, however, are not unique in their capacity to generate distinct cell types. In fact, their closest
living relatives, a group of aquatic, unicellular, bacterivorous protists called choanoflagellates, detect biotic and
abiotic cues to differentiate into phenotypically and functionally distinct cell types in different environments.
Choanoflagellates also possess critical genes that regulate animal cell differentiation during development,
supporting the hypothesis that cell differentiation mechanisms evolved prior to the origin of animals and
became integral in animal and choanoflagellate biology.
Although nearly 800 million years of animal evolution has shaped human biology since we last shared a
common ancestor with choanoflagellates, the commonalities in genetic toolkits and cytological characteristics
indicate that choanoflagellates have tremendous potential as microeukaryotic models to investigate the core
functions of genes that regulate cell differentiation. During my postdoc, I pioneered the first methods for gene
delivery and genome editing in the choanoflagellate Salpingoeca rosetta to realize its full potential as a model
system. My lab continues to propel those methods for the discovery of the molecular mechanisms that drive
environmentally-triggered cell differentiation in S. rosetta. This proposal supports our research mission by using
the molecular tools I developed to dissect putative regulatory pathways that emerge from functional genomic
surveys. In particular, we focus on homologs of RNA-binding proteins that form the animal germline and and/or
maintain pluripotency. Moreover, we strive to develop our nascent genetic tools into scalable, easy methods that
enable genome-wide screens of cell differentiation regulators. Overall, this work will contribute a new, functional
comparison to illuminate the origin and evolution of cell differentiation pathways in choanoflagellates and
animals, which I anticipate will uncover core functions of biomedically important genes that originated before
choanoflagellates and animals diverged.

Public health relevance
PROJECT NARRATIVE The differentiation of cells into functionally distinct types enables animals to build multicellular bodies and allows their closest-living relatives, choanoflagellates, to take advantage of different environments. Based on our working model that choanoflagellates and animals evolved cell differentiation programs from a common, ancestral genetic toolkit, this proposal advances molecular genetic tools in choanoflagellates to investigate the mechanisms that govern cellular differentiation in these aquatic microeukaryotes. This work will provide novel functional data to highlight the conservation or divergence or regulatory mechanisms in choanoflagellates and animals, thereby illuminating the core functions of genes that were foundational for the origin of animals and that remain integral for human biology.